Rutgers Center for Environmental Exposure and Disease (CEED)

OVERALL: ABSTRACT
The theme of the Rutgers Center for Environmental Exposures and Disease (CEED) is Precision
Environmental Health (PEH) research, which we define as the integration of data from exposure biology,
genomics, epigenetics, and microbiomics to identify biological responses that are mechanistically
linked to pathogenesis and that will inform disease prevention. The mission of CEED is to improve health
and diminish the impact of environmental toxicants and stressors by reducing exposures and mitigating their
adverse biological effects. Our vision is that a PEH research approach can better inform the development of
precise and targeted prevention/intervention strategies. Our strategy is to recruit and train investigators who
can integrate information-rich data streams from new technologies with the Center’s longstanding expertise in
clinical, basic, population-based, and community engaged research to reduce the burden of environmental
disease, especially in vulnerable and environmental justice communities, which bear the greatest burden of
exposures and health disparities. To achieve our strategic vision, CEED is formed as a hub of transdisciplinary
research, combining access to cutting-edge technologies and computational approaches with a team of
outstanding scientists with expertise in exposure science, mechanistic toxicology, modeling and bioinformatics,
human research, epidemiology, and community engagement. CEED aims to reduce adverse health effects of
toxicants and stressors through transdisciplinary PEH research that considers all aspects of the individual’s
responsiveness that contribute to disease pathogenesis and that uses this information to design
mechanistically-guided intervention and prevention strategies. We aim to engage communities and
stakeholders in multidirectional interactions and participatory research to: 1) identify exposures that are of
concern to communities and have the potential to adversely affect human health; 2) assess and model the
extent of exposures in affected populations; 3) identify cofactors (i.e., psychosocial factors, age, sex, genetics,
co-morbidity, etc.) and assess their impact on individual responsiveness to toxicants; 4) discover and use
biological response indicators that link exposures to mechanisms of disease pathogenesis; 5) develop and
implement mechanistically-driven prevention, intervention, and treatment strategies; 6) reduce exposures and
mitigate health effects by informing systems changes that alter behaviors, practices, policies and regulations.

Public health relevance
OVERALL: NARRATIVE The mission of CEED is to improve public health by bringing together and training researchers interested in environmental health who will work cooperatively to reduce exposures and mitigate the effects of environmental toxicants on at-risk, vulnerable and environmental justice communities. To accomplish this mission, CEED has formed a hub of accomplished researchers with expertise in exposure science, mechanistic toxicology, modeling and bioinformatics, clinical research, epidemiology and community engagement. Our strategic vision is to reduce adverse health effects of toxicants and stressors through Precision Environmental Health, a transdisciplinary research approach that: 1) assesses complex relationships between toxicants and health in the context of factors that modulate individual responsiveness, including genetics, epigenetics, microbiomics, age, sex, diet, co-morbidities, psychosocial stress, and social structures and constructs; 2) identifies biological response indicators that link exposure to mechanisms of disease pathogenesis; and 3) uses this information to design mechanistically guided, targeted intervention and prevention strategies to reduce exposures and disease.